The Ethics of Engagement in Patient-Focused Drug Development for Rare Diseases

Project Summary: Patient and family groups (PFGs) have long supported rare disease research as
fundraisers and advisers. But today, they increasingly drive the research agenda, working in partnership with
academic institutions, drug developers, and regulators to shepherd new therapies from basic research to
commercialization. While patient engagement has become common in many areas of biomedical research, this
model of PFG-led, therapy-focused, collaborative research—known as “patient-focused drug development”
(PFDD)—is especially prominent in the rare disease space, where small patient populations, dispersed
expertise, and limited financial incentives for drug discovery necessitate active engagement of PFGs across
the drug development pipeline. When collaborations are successful, PFDD can fuel scientific advancement and
accelerate cures for rare diseases with limited therapeutic options. However, this emerging model has also
created new ethical challenges, as PFGs and their partners navigate competing values, interests, and
expectations throughout the PFDD process. These ethical challenges have the potential to disrupt PFDD,
erode trust, consume scarce resources, and exacerbate inequities, but they remain poorly understood. The
objective of this proposal is to gain a multi-perspective account of ethical challenges raised by PFDD in rare
diseases and to use collaborative methods to develop tools to manage these challenges. Our proposal
includes three specific aims. Aim 1: To explore stakeholder perspectives on the ethical challenges arising in
PFDD, as well as ways in which they currently manage these challenges, though semi-structured interviews
with representatives of key stakeholder groups including PFGs representing a variety of rare diseases,
academic institutions, industry partners, government agencies and rare disease umbrella organizations. Aim 2:
To characterize the values, interests, resources, roles, and relationships of stakeholder groups, and to identify
nodes of conflict and alignment of values and interests within and across groups, suggesting additional ethical
challenges and management strategies, using the framework of stakeholder analysis. Aim 3: To evaluate the
tradeoffs and downstream implications of potential strategies for managing ethical challenges identified in Aims
1 and 2, to seek multi-stakeholder consensus regarding recommended strategies, and to develop an
implementation strategy. We will engage representatives of key stakeholder groups in a conventional Delphi
panel consisting of three rounds of iterative surveys and an in-person consensus meeting. Our study will
culminate in an “ethics roadmap” outlining the ethical challenges stakeholders may encounter in PFDD and
recommended approaches to managing or resolving these challenges. The roadmap will have a positive
impact by helping stakeholders anticipate, understand, and respond to the ethical challenges they may
encounter at each stage of PFDD. Future work will evaluate the impact of the roadmap on the process and
outcomes of PFDD for rare diseases and will seek to adapt it for other types of research.

Public health relevance
PROJECT NARRATIVE Rare genetic diseases collectively affect millions of individuals in the United States and, due to few available treatments, contribute substantially to population morbidity and mortality. Recent advances in genomics and related technologies offer new avenues for the development of treatments but require collaboration among a broad range of stakeholders, including patient and family groups. Understanding and addressing the ethical challenges arising in this new era of patient-focused drug development is essential to ensure the successful and ethical development of new therapies for rare genetic diseases.